PRECLINICAL TOXICOLOGY (WS#52) -CHRONIC ORAL TOXICITY S

The investigators will conduct 6-month, chronic oral toxicity studies of two isoflavone compounds in rats. Endpoints will include food and water consumption, body weight, clinical observation, ophthalmic assessment, clinical chemistry and hematology, plasma test agent levels, urinalysis, and anatomic and histologic pathology. Dose associated toxicities will be identified.